PositiveLinks for Youth and Emerging Adults (PL4Y): Adapting a multimodal evidence-based mHealth intervention to increase engagement in HIV care in the Southern US

Project Summary
Emerging adults and youth living with HIV 18-29yo (YLWH) are the least likely of any age group to engage in
care or achieve virologic suppression, and Southern YLWH live at the epicenter of the modern U.S. HIV
epidemic. In Texas, molecular clusters of rapid HIV transmission among youth highlight missed opportunities
including delays in care engagement and virologic suppression, and less than 20% of YLWH in our target
population in South Texas achieve virologic suppression. Our long-term goal is to improve rates of virologic
suppression for YLWH through development of a novel mobile health (mHealth) tool for care engagement.
mHealth interventions, such as smartphone applications (apps), are rapidly adopted by youth, and are an
underutilized resource in increasing care engagement for YLWH. This project proposes to adapt and pilot test
the efficacy of an existing mHealth tool, the PositiveLinks Program (PL), developed by Dillingham and Ingersoll
(Co-Is). Pl is a multimodal intervention, including daily adherence assessment, appointment reminders, secure
messaging with clinic providers, and an online anonymized peer support network. PL increased care
engagement and virologic suppression in adults (majority >40yo) with HIV in observational studies, but has not
been studied in YLWH. Formative research by Taylor (PI), Nijhawan (Co-I), and Villarreal (Co-I) showed that
patients and providers in Texas seek relational interventions and YLWH request mHealth approaches for
engagement. We will use the Theory of Planned Behavior (TPB) as a theoretical model and Positive Youth
Development (PYD) as an approach to rigorously adapt and pilot test a modified version of PL, PositiveLinks
for Youth (PL4Y).
To do so, we will conduct a rigorous formative evaluation of PositiveLinks to adapt it to the needs of YLWH,
including: semi-structured interviews informed by TPB with YLWH experiencing challenges with care
engagement and stakeholders, and feedback from a Youth Advisory Board (Aim 1). We will then develop and
iteratively adapt components of PL and new youth-focused components emerging from the formative
evaluation with YLWH who are newly diagnosed, disengaged in care, or not virologically suppressed using a
human-centered design approach informed by PYD to generate PositiveLinks for Youth (PL4Y) (Aim 2).
Finally, we will conduct a small pilot randomized control trial of the adapted PL4Y program in YLWH
disengaged from or newly engaging in HIV care to assess its impact on virologic suppression (Aim 3). A mixed
methods process evaluation will assess acceptability and feasibility of this novel intervention.
Through these aims we will develop an innovative care engagement tool that caters to the developmental and
socio/structural needs of YLWH. Our approach can serve as a model for efficient adaptation of mHealth
interventions to new target audiences in response to an urgent community need.

Public health relevance
Project Narrative Youth and emerging adults living with HIV (18-29yo) are the least likely of any age group to engage in HIV care or achieve virologic suppression. By rigorously adapting an existing mobile health intervention to the specific needs and developmental stage of youth and emerging adults with HIV, with direct input from youth throughout this process, we can generate a powerful and effective tool to increase care engagement and improve health outcomes for this vulnerable population. Our proposal will also advance our knowledge on the utility, acceptability, and processes of development for mHealth interventions for youth living with HIV.